BOUNCE: Development of a trauma-informed mHealth + peer support intervention to promote PrEP uptake among men who have sex with men

PROJECT SUMMARY/ABSTRACT
HIV pre-exposure prophylaxis (PrEP) uptake has progressed slowly for gay, bisexual, and other men who have
sex with men (MSM) in the United States, a population disproportionately burdened by HIV. Addressing trauma
and related sequelae may help optimize PrEP uptake in this population, as MSM are disproportionately
exposed to trauma, particularly interpersonal violence, much of which is motivated by prejudice. Interpersonal
violence carries the highest conditional risk of any trauma exposure for developing posttraumatic stress
disorder (PTSD), risk which is further amplified when the violence is motivated by prejudice. Substance use
often occurs in response to trauma exposure and may co-occur with PTSD symptomology. There is limited but
compelling evidence to suggest that violent trauma exposure, PTSD symptomology, and substance use may
negatively affect PrEP uptake. However, research with large MSM-only samples that examines these pathways
(with temporal ordering) is lacking, as are trauma-informed PrEP interventions for MSM.
This K01 will provide the candidate, Dr. John Mark Wiginton, with the expertise, skills, and opportunities
necessary to examine prejudice-motivated interpersonal violence and PrEP uptake pathways among MSM
using latent class mediation (Research Aim 1); apply these findings, along with qualitative data from
community-engaged research with local MSM and stakeholders, toward development of a novel trauma-
informed mHealth + peer support intervention (called BOUNCE) targeting PrEP and coping self-efficacy,
peer/social support, and resilience factors (safety, autonomy, trust, trauma awareness) to support PrEP uptake
among MSM (Research Aim 2); and conduct usability testing and a proof-of-concept pilot of BOUNCE to
assess feasibility, acceptability, and PrEP uptake.
Dr. Wiginton will utilize UCSD’s training infrastructure to build his professional independence and further
cultivate his competence to develop and test trauma-informed HIV prevention interventions tailored to sexual
and gender minorities, particularly those who are multiply-marginalized, to improve HIV disparities and broader
sexual health and psychosocial wellness in these populations. Dr. Wiginton seeks training to build his topical
and theoretical expertise in trauma exposure, PTSD symptomology, associated substance use, and health
behavior impacts (Training Aim 1); gain knowledge and experience conducting community-engaged research
(Training Aim 2); develop expertise in designing trauma-informed mHealth + peer support interventions
(Training Aim 3); build competence in early-phase clinical trial methods and approaches to evaluate behavioral
interventions (Training Aim 4); and foster personal and professional development skills (Training Aim 5). With
this award, Dr. Wiginton will gain not only exceptional training, but also valuable data, from which to build his
research independence with a competitive future R34/R01 to test BOUNCE more rigorously.

Public health relevance
PROJECT NARRATIVE Gay, bisexual, and other men who have sex with men (MSM) in the United States shoulder a disproportionate burden of HIV, trauma exposure (especially interpersonal violence that is often motived by prejudice), and associated PTSD and substance use, which may negatively impact uptake of HIV pre-exposure prophylaxis (PrEP), an effective HIV-preventive biomedical intervention. Latent class mediation analysis can identify the extent to which distinct and unique patterns of PTSD symptomology and substance use mediate the effect of prejudice-motivated violence on PrEP uptake in this population, and in conjunction with qualitative findings from local violence-exposed MSM and key community stakeholders can inform a novel trauma-informed mHealth + peer support intervention to support PrEP uptake, contributing to a reduction in HIV transmission and related disparities. Through this K01, Dr. Wiginton will leverage the UCSD training infrastructure to build his professional research independence for improving PrEP uptake among marginalized populations through innovative trauma-informed approaches, positioning him as a leader in the next generation of queer scholars to contribute toward ending the HIV epidemic among racially/ethnically diverse MSM in the United States.